Role of mTOR Hyperactivation in Pulmonary Vascular Remodeling

Project Summary
Pulmonary hypertension (PH) is a devastating lung disease characterized by pulmonary vascular
remodeling and associated with high morbidity and mortality. Discovery of new therapeutic targets in PH has
been limited by the heterogeneity in disease endotypes and incomplete mechanistic insight into the cellular
processes that control and perpetuate vascular remodeling. Recently, the mechanistic target of rapamycin
(mTOR) signaling pathway has been implicated in the development and progression of PH, including pulmonary
arterial hypertension (PAH). Despite the growing importance of mTOR activation in pulmonary diseases, the
effects of mTOR hyperactivation on pulmonary cells and the contribution of mTOR to the development and
progression of vascular remodeling remains incompletely understood.
In my preliminary data, I demonstrate that mesenchymal cells will act as a signaling hub after selective
deletion of tuberous sclerosis complex 2 (Tsc2) and subsequent mTOR activation in progenitor mesenchymal
cells (Tbx4LME-CreTsc2Mesenchymal KO). These cells orchestrate dysregulated cellular responses in arterial endothelial
cells (ECs), leading to pulmonary vascular remodeling and spontaneous PH in Tsc2M-KO mice. This proposal will
expand on this finding and examine how mTOR activation in specific mesenchymal populations alters EC
behavior, function and trajectory and how aberrant mTOR signaling contributes to pulmonary vascular
remodeling. To accomplish this task, I will utilize three novel mouse models with mTOR activation in distinct
mesenchymal populations. To understand the disease relevance of the murine models, I will be performing
concurrent experiments on primary lung tissues from lymphangioleiomyomatosis (LAM) and PAH. LAM is a
monogenic disease with mTORC1 activation in lung mesenchyme cells. In additional to parenchymal changes,
a subset of patients with LAM develop pulmonary vascular remodeling and PH. As a monogenic disease, LAM
is an ideal model for the study of mTOR activation on EC biology and pulmonary vascular remodeling.
This proposal leverage my expertise in pulmonary vascular biology, ex vivo model systems and in vivo
experience with transgenic murine lines to generate significant discoveries regarding the fate regulation and
function of endothelial cells in pulmonary vascular remodeling. My training, composed of coursework/workshops
in bioinformatics and epigenetics, will take place under the mentorship of Dr. Vera Krymskaya, a leader in mTOR
research. To ensure that I am meeting research and academic milestones, I have compiled a diverse but
complementary Advisory Committee. Upon completion of this work, I will develop additional comprehensive skills
in epigenetic analysis and advanced bioinformatics, ex vivo lung modeling, and in vivo murine models. Together,
the research and career development plans proposed herein will facilitate a better understanding of the cellular
crosstalk in the pulmonary microenvironment while preparing me for my future career as an independent
investigator in the field of vascular biology.

Public health relevance
Project Narrative Mechanistic target of rapamycin (mTOR) is a highly conserved signaling network upregulated in a number of proliferative lung diseases including pulmonary arterial hypertension (PAH) and lymphangioleiomyomatosis (LAM). This proposal uses three transgenic mouse lines and primary PAH and LAM lung tissues to investigate the role of mTOR hyperactivation on pulmonary vascular remodeling and pulmonary hypertension. The results from this work will help define the role of aberrant mTOR signaling on cellular crosstalk and identify mechanisms of vascular remodeling that can be harnessed to provide potential new therapeutic targets.